2022 Craniofacial Morphogenesis and Tissue Regeneration Gordon Research Conference and Gordon Research Seminar

Project Summary
Goals of craniofacial research are to better understand normal development, the causes underlying craniofacial
malformations, and how best to develop diagnostics and therapies to repair craniofacial tissues. In-depth
interdisciplinary understanding of developmental biology, craniofacial disease processes and tissue repair can
provide essential insight into mechanisms regulating craniofacial morphogenesis and regeneration, and the
translation of scientific outcomes to effectively treat the wide variety of clinical disorders affecting the head and
face. Such in-depth understanding requires detailed knowledge of the cellular events and molecular signals that
control craniofacial tissue patterning, development and repair, and the morphogenetic processes that shape
craniofacial tissues and organs.
Contemporary developmental studies of the vertebrate craniofacial complex employ multidisciplinary
approaches including developmental biology, functional genomics, biomedical engineering, biophysics, and
molecular and cellular biology. The study of craniofacial development utilises a wide range of vertebrate and
invertebrate models, which collectively provide a variety of experimental approaches to investigate the molecular
and cellular mechanisms underlying the morphogenesis of craniofacial structures in both health and disease.
These models also offer insight into the evolutionary forces and environmental factors driving the diversity of
craniofacial form and function. As such, research in craniofacial development is a key discipline of developmental
and cellular biology and aligns well with the scope of prominent peer-reviewed journals.
The 2022 Craniofacial Morphogenesis and Tissue Regeneration GRC/GRS proposed here will highlight how
interdisciplinary research is rapidly expanding our understanding of craniofacial development and tissue
regeneration through talks investigating the integration of molecular and biomechanical signals regulating
craniofacial development. Such interdisciplinary approaches are being used to elucidate how developing
craniofacial tissues and their environment interact to create craniofacial form and function. The proposed
presentations will be accompanied by extensive discussions on how these processes drive the diversity of
craniofacial structures, and how many distinctive features of the vertebrate head have evolved.
Invited presentations by new and established researchers will discuss new findings in craniofacial
morphogenesis and tissue regeneration, with specific focus on the role of mechanical and bioelectric signaling
in craniofacial development and tissue regeneration. The meeting will also feature sessions on cell signalling,
clinical genetics, sense organs, new animal models of craniofacial disorders, and on novel tissue engineering
strategies for regenerative craniofacial tissue repair. The program is designed to promote interactions of basic
science researchers, clinician scientists, biomedical engineers and evolutionary biologists of diverse expertise,
in order to foster stimulating discussions and productive new collaborations in a highly collegial atmosphere.

Public health relevance
Project Narrative: Craniofacial abnormalities involving the highly complex and integrated tissues of the head represent one third of all birth defects. This conference aims to showcase the latest research findings on how the craniofacial complex forms, what goes wrong in the case of birth defects and genetic disease, and how Tissue Engineering and Regenerative Medicine and Dentistry strategies can be used to achieve the effective repair of craniofacial tissues in a highly aesthetic and functional manner.